Administrative Core

SUMMARY/ABSTRACT: ADMINISTRATIVE CORE
The Partnership for Native American Cancer Prevention (NACP) is a 16-year collaboration between
Northern Arizona University (NAU, an institution serving underserved heath disparity populations and
underrepresented students (ISUPS)) and the University of Arizona Cancer Center (UACC, a National Cancer
Institute-designated comprehensive cancer center). The overarching goals of the NACP are to reduce the
cancer burden within the Native American population through research and community engagement; expand
the number of Native American investigators working in cancer research; and increase the total number of
investigators focused on cancer health disparities within the Native American communities of Arizona.
The NACP Administrative Core is the organizational component that brings together the inter-
institutional leadership to coordinate goals and aims of the Partnership. Additionally, the Core ensures that
each of the other components of NACP (Cores, Shared Resource, and research projects) have aims and
activities that align with these goals. The Administrative Core provides essential administrative services
across these components to guarantee effective and efficient coordination, financial management, and
documentation of all activities as well as facilitates the interactions with the three NACP advisory committees –
Internal Advisory Committee, Program Steering Committee, and the Community Advisory Committee. Given
the 255-mile distance separating the two institutions and the dispersed locations of many of the advisors, the
Administrative Core's fundamental roles must include promoting effective communications as well. The
Administrative Core will also initiate recruitment of Early Stage Investigators focused on cancer health
disparity research that will serve tribal communities.
To ensure the success of NACP's goals and strategic plan outlined throughout this application, the
Administrative Core is charged with the following aims:
Aim 1. Engage a Partnership leadership team that integrates all Research Projects, Cores, and Shared
Resource activities in support of NACP goals.
Aim 2. Provide administrative management for the entire partnership including facilitating communication
between Cores and Projects, and fiscal management of all components.
Aim 3. Coordinate the participation of the Internal Advisory Committee, Program Steering Committee,
and Community Advisory Committee within NACP's planning and evaluation activities.
Aim 4. Initiate the recruitment process of Early Stage Investigators to enable their successful career
development and to increase the number of Native American investigators at both institutions.